The Impacts of Mitigation Strategies to Prevent COVID-19 Transmission in American Indian Communities

OTHER PROJECT INFORMATION – Project Summary/Abstract
The Impacts of Mitigation Strategies to Prevent COVID-19 Transmission in American Indian Communities
Very little is known about the impact of locally-mandated COVID-19 mitigation policies such as Non-
Pharmaceutical Interventions (NPI) on the health and wellbeing of medically and economically vulnerable
populations such as American Indians (AI) living in rural tribal lands. There is an urgent need to evaluate the
effect of already implemented measures on the spread of COVID-19, the social and economic impact of those
measures in these communities, and the potential spillover effects on non-AIAN communities. The staggered
nature of the NPI implementation in tribal lands and the independence of sovereign nations’ policy decisions
from local (e.g. county-level) policies present a unique quasi-natural experiment in policy timing, allowing us to
study spillover effects from tribal NPIs to connected non-tribal areas. Our research efforts seek to improve
American Indian health by understanding and evaluating these NPI measures on an NIH-designated disparity
community. This R01 proposal has four specific aims: (1) Identify whether COVID-19 cases and deaths are
related to the early closure of American Indian reservations and/or tribal casinos among Native and non-Native
populations living on and off of adjacent reservation lands. (2) Identify the change in commuter patterns and
movement behaviors as a result of NPIs. (3) Use in-time claims data to analyze how the implementation of NPIs
and the progression of the epidemic affected utilization of different non-COVID-19 health care services and
facilities. (4) Conduct a survey of American Indians living in rural areas to create a new primary data resource
and cross-validate the results we obtain through analysis of secondary data of cell phone traffic flows. The long-
term goal of this proposal is to develop and validate analytical tools that could be applied with large secondary
datasets to aid the evaluation and design of public policies to address public health emergencies in AI
populations. Our central hypothesis is that the timely implementation of tribal NPIs reduced the incidence of
COVID-19 cases and deaths in AI communities and in traffic-connected areas. However, we also expect that the
secondary effects of NPIs, such as economic hardship and under-utilization of non-COVID-related health care,
would be stronger on tribal lands. We will use an innovative two-pronged approach to combine empirical analysis
of secondary big data sources with primary data collection to provide robust evidence on the current and future
effects of these policies. This proposal is significant because the impact of COVID-19 and related policies on
tribal communities is under-researched, under-funded, and not well understood, and yet relevant not only for AI
tribal policies and populations but for regional health and economic policies. Our research is guided by the
C.A.R.E. Principles of Indigenous Data Governance developed by our team members. It is innovative because
it applies techniques from economics, computer science and public health to deliver actionable results and
recommendations for future policy implementation.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative The COVID-19 pandemic and associated mitigation strategies have been shown to disparately impact socially vulnerable and under-served minority groups in the US. This proposed study develops an innovative approach to analyzing the effects of COVID-19 mitigation policies on American Indian populations living on tribal lands and in rural areas, by integrating big data and deep learning techniques with primary data collection. Our research efforts seek to improve American Indian health by understanding and evaluating these NPI measures on an NIH- designated disparity community.